Response-contingent learning to modulate synaptic plasticity for spinal cord injury

Project Summary/Abstract
Over 17,000 new cases of spinal cord injuries (SCIs) are experienced annually in the U.S. due
to motor vehicle collisions, sports injuries, and other traumatic events. In addition to the loss of
mobility, numerous complications including urinary tract infections, pressure sores, and chronic
central neuropathic pain (CNP) significantly impact the quality of life and contribute to morbidity
and mortality. However, no effective treatments exist for individuals with SCIs. A mechanism-
based approach that based on individual spinal learning to promote motor recovery and re-
balance the pain circuitry would be the key to developing personalized SCI treatment. In the
New Innovator Award program, our team will develop novel response-contingent
neuromodulation devices to electrically modulate neural circuit plasticity. This individualized
treatment strategy will be based on establishing a close-loop electrical stimulation paradigm via
novel design of neuromodulation to self-train spinal circuitry. Our team will assess if the motor-
contingent electrical stimulation can promote motor recovery and pain sensitization and
investigate the underlying molecular mechanisms associated with spinal plasticity using the rat
SCI model. The proposed work will determine the biology behind adaptive plasticity associated
with NP and lay down the foundation to develop a close-loop electrical modulation technology
for individualized neurotrauma treatment in the future.

Public health relevance
Project Narrative Spinal cord injuries (SCIs) cause lifelong disabilities (e.g., chronic central neuropathic pain) and levy an enormous socioeconomic toll. However, there are no effective treatments currently available for individuals. This proposal will utilize novel neuromodulation approach to promote spinal learning and adaptive plasticity for individualized treatment strategy.